UCLA IDDRC

This proposal requests 5 years of additional funding for the UCLA Intellectual and Developmental Disabilities
Research Center (IDDRC). For over 40 years, our mission has been to provide an optimal environment for
conducting multidisciplinary research into the mechanisms underlying intellectual and developmental disabilities
(IDDs), to translate these findings into effective treatments for IDDs, and disseminate these findings to the
scientific community and the public. This submission expands on the translational focus that we began 5 years
ago with an added emphasis on human research and clinical trials, and closer ties to the community. Each of
the 5 cores are structured to facilitate interdisciplinary collaborations, following four thematic goals: 1) providing
state of the art infrastructure for IDD related research; 2) encourage innovation by supporting technical
development and providing financial incentives for new projects; 3) promote integration across disciplines, by
encouraging interdisciplinary research among faculty and between cores; and 4) to disseminate advances in
technology to other scientists, train new IDD investigators, and convey findings to the scientific community and
stakeholders in community outreach efforts. We propose 5 interacting cores: A: Administration and
Dissemination, which oversees core functions and usage, assures quality and accountability, and promotes
outreach and dissemination; B: Clinical Translation, supporting clinical trials, recruitment, diagnosis and deep
phenotyping, and biosample collection; C: Genetics, Genomics and BioInformatics, which performs genetic
analysis, sequencing, expression, and provides resources for planning and executing analysis of genomics data;
D: Cells, Circuits and Systems, supporting human iPSC and 3-dimensional organoid development, in- and ex-
vivo electrophysiology and optogenetics; and E: Structural and Functional Visualization, which provides training,
access, and analysis services for in vitro microscopy, mini-cameras for in vivo visualization, animal and human
structural and functional MRI and spectroscopy. Our model research project focuses on mechanisms underlying
sleep impairments in two IDDs, building on new findings from our last submission: a near absence of slow-wave
sleep in Dup15q syndrome. We will examine mechanisms underlying sleep impairments in Dup15q and Rett's
Syndrome using a multidisciplinary approach that includes a clinical component, animal models, and brain
organoid model using patient-derived IPSCs, to elucidate how mechanisms underlying altered sleep physiology
lead to cognitive dysfunction. Results from this project will directly inform next steps for developing interventions
that may modulate sleep and, in turn, neurodevelopment in IDDs.

Public health relevance
For over 40 years, the UCLA IDDRC has committed to improving the lives of individuals with intellectual and developmental disabilities (IDDs) through basic and translational research, education, and outreach. Our center aims to provide outstanding resources and infrastructure to UCLA researchers focused on IDDs using the most innovative technologies that will significantly impact the well-being of individuals with IDDs and their families. This application requests 5 years of funding to support our Core infrastructure and a novel multidisciplinary project that examines the origins of abnormal sleep physiology and cognition. A new dissemination program extends our reach into the community to enhance inclusiveness and two-way communication with the public and stakeholders.